Brown/WIH Pelvic Floor Disorders Network Site (UG1)

Project Summary: The Pelvic Floor Disorders Network (PFDN) is an ongoing multicenter program designed to study clinical and health aspects of female pelvic floor disorders (PFDs). Women & Infants Hospital (WIH) is a women’s hospital, uniquely focused on advancing women’s health and research and its mission is directly in line with the PFDN. The Brown/WIH site has demonstrated that we have the scientific expertise, high clinical volume, research infrastructure, and administrative commitment to be successful in this Network. The objective of this administrative supplement is to complete the work for active ongoing PFDN protocols including: 1) MUSA (in active enrollment, randomizing women with mixed incontinence to sling surgery vs. onabotulinumtoxinA), 2) PRoMISe (in active enrollment, supplementary study to MUSA characterizing baseline putative proteins in women with mixed incontinence associated with change after treatment), 3) BioLIFT (active study evaluating the feasibility of biofabrication of pelvic ligaments), 4) e-ASPIRE (in follow-up, comparing 3 surgical approaches for vaginal prolapse), and 5) e-SUPeR (in long-term follow-up comparing native tissue to mesh based surgery for uterine prolapse). During the next year, our focus will be to work diligently with our collaborating sites and the coordinating center to complete recruitment and follow-up for the MUSA trial, continue our innovative, collaborative work with Pittsburgh and biomedical tissue engineering at Brown for BioLIFT, and to maintain high retention rates in all clinical trials. We will continue to ensure active Network participation including high data quality, manuscript proposal and publication, and active support of all Network administrative functions. We will also continue to ensure the highest quality of care and research for women with PFDs in New England through wider-reaching advocacy efforts.

Public health relevance
Project Narrative: As the demand for pelvic floor disorders care continues to grow, high-quality, collaborative research is critically needed. Brown/WIH is committed to the Pelvic Floor Disorders Network and conducting high-impact research that will help to improve the quality of life of women suffering from these conditions.